HORMONAL REGULATION OF AMINO ACID METABOLISM IN NORMAL HUMANS

Examine in normal humans the role that insulin, glucagon, epinephrine and norepinephrine play in regulating glucose and amino acid metabolism in man.